Poly-Nucleic acid complexes for chemokine modulation of the tumor microenvironment

Nucleic acids are poised to become the next generation of cancer therapeutics, and the current standard for
nucleic acid delivery is lipid nanoparticles. Lipid nanoparticles can effectively deliver mRNA and siRNA in vaccine
and therapeutic settings, both preclinically and clinically. This work seeks to develop a polymer-based delivery
system for nucleic acids, which may hold multiple advantages over current lipid nanoparticle technologies. A
Poly(2-0xazoline) platform for delivering mRNA can produce smaller particles sizes and utilize PEG alternatives
in forming polymer-nucleic acid complexes. Smaller sized particles can reduce the significant passive
accumulation in the liver and non-PEG polymers can mitigate anti-PEG antibody-based responses. This proposal
will investigate these particles in the setting of triple negative breast cancer. Triple negative breast cancer is
heterogeneous and highly immunosuppressive, with poor infiltration of key immune cells rendering modern
therapies ineffective. By increasing the presence of these key immune cells, therapeutic outcomes can be
improved in triple negative breast cancer. This work proposes to deliver mRNA for the key chemokine, CXCL 1,
to recruit conventional type 1 dendritic cells to the tumor. These cells are responsible for identifying tumor
antigens, translocating to the lymph node, and training T-cells to identify and combat cancer cells. With increased
T-cell infiltration, tumors will increase in their sensitivity to checkpoint inhibitor therapy, a critical piece of current
treatment paradigms. Our polymer-nucleic acid complexes will target cancer associated fibroblasts, the most
abundant cell in the tumor microenvironment, for CXCL 1 mRNA delivery. Aptamers targeting cancer associated
fibroblasts will allow us to improve mRNA delivery efficiency to the solid tumor, while mitigating potential side
effects from off-target delivery. By hijacking cancer associated fibroblasts, we can utilize a cell which is a key
regulator of the immunosuppressive microenvironment to attract dendritic cells to the tumor for antigen
presentation-making them a key contributor to the anti-cancer response. Dendritic cells will go on to present
antigen to T-cells, priming them for anti-cancer activity and homing to the tumor. This will sensitize these tumors
to checkpoint inhibitor therapy by increasing the number of T-cells in the tumor. The successful completion of
this project will validate the use of targeted polymer-nucleic acid complexes for gene delivery and demonstrate
the viability of chemokine-based treatment paradigms. This is the first step towards chemokine-cocktail
immunotherapies, which could target multiple immune cell populations for precision activation of the immune
system against cancer.

Public health relevance
Nucleic acid-based therapies are poised to become the next generation of cancer therapies and can be readily adapted for individualized treatment. Developing alternative delivery methods outside of Lipid Nanoparticles for targeted treatment will increase opportunities for treatment and open new treatment paradigms. This proposal aims to understand how polymers interact with nucleic acids and develop new methods for targeting nucleic acids to solid tumors to improve cancer therapy through chemokine-based immunomodulation.